Project 1: Chimeric antigen receptor T-cell therapy for T cell malignancies

Project 1 Abstract
The long-term goal of this project is to improve chimeric antigen receptor T cell (CAR-T) therapy for
patients with T-cell Acute Lymphoblastic Leukemia (T-ALL) via the use of ‘off-the-shelf’ universal
allogeneic CAR-T (UCART) cells. T cells engineered to express a chimeric antigen receptor (CAR) are a
promising cancer immunotherapy. However, T cell malignancies pose a challenge to CAR-T cell therapy due to
the shared expression of target antigens between normal and malignant T cells. CD7 is highly expressed in T-
ALL and the majority of normal peripheral T cells and NK cells. To overcome this shared antigen expression
problem, our group has developed CAR-T cells targeting CD7 that are genetically edited using CRISPR/Cas9 to
lack both CD7 and the T cell receptor alpha chain (TRAC) in order to avoid fratricide and permit the use of
allogeneic T cells for treatment of T-ALL. In our preclinical studies, these universal allogeneic CAR-T targeting
CD7 (UCART7) prevented fratricide and efficiently killed human T-ALL cell lines and patient-derived primary T-
ALL in vitro and in vivo without causing xenogeneic graft-versus-host disease (GVHD). We hypothesize that
the administration of allogeneic UCART7 cells to patients with relapsed or refractory (r/r) T-ALL will be
safe, tolerable, and provide anti-tumor activity resulting in improved clinical outcomes. We plan to test
this hypothesis in Aim 1 by conducting a phase 1 trial titled “A Phase 1/2 Study of the Safety and Efficacy of
Anti-CD7 Allogeneic CAR-T cells (WU-CART-007) in Patients with r/r T-ALL/LBL”. Correlative studies will
characterize the phenotype and function of UCART7 and their effects on (1) serum cytokines, (2) endogenous
CD7-expressing cells, (3) other cell subsets lacking CD7 and (4) T-ALL using cytokine bead arrays, flow
cytometry, CITE-seq, and single cell cytokine analyses. Three obstacles to effective CAR-T cell therapy,
including potentially UCART7, are (1) cytokine release syndrome (CRS), (2) suboptimal CAR-T cell cytotoxicity
and persistence and (3) relapse due to antigen escape via downregulation or mutation of the CAR-T target
antigen. IL-7 and IL-15 are the main regulators of peripheral homeostatic expansion of CD4 and CD8 T cells.
NT-I7 and N-803 are long-acting derivatives of IL-7 and IL-15, respectively, that are safe and well tolerated in
mice and man. Furthermore, duvelisib, a dual phosphoinositide 3-kinase delta/gamma (PI3Kdg) inhibitor, may
provide effective prophylaxis against CRS while enhancing the persistence and efficacy of CAR-T cells. We
hypothesize that NT-I7 or N-803 in combination with duvelisib can promote UCART proliferation,
persistence, and T-ALL killing in mice resulting in long-term tumor-free survival in the absence of CRS.
We plan to test this hypothesis in Aim 2 using xenogeneic and immunocompetent mouse models of T-ALL.
Finally, multi-antigen-targeted CAR-T cells are a promising direction to overcome single antigen relapse issues
following CAR-T cell therapy. As part of Aim 2, we will evaluate if “dual-targeting” of CD7 and CD2 in T-ALL can
mitigate the risk of antigen escape and relapse.

Public health relevance
Project 1 Narrative T cell malignancies represent a class of hematologic cancers with high rates of relapse and mortality in both children and adults for which there are currently no effective or targeted therapies. We have developed a fratricide-resistant “off-the-shelf” chimeric antigen receptor T cell that targets CD7+ T cell malignancies (UCART7) and, through CRISPR/Cas9 gene editing, lacks both CD7 and T cell receptor alpha chain expression thereby preventing graft-versus-host disease when infused into allogeneic recipients. We propose to test UCART7 in patients with relapse or refractory T-cell Acute Lymphoblastic Leukemia (T-ALL) and use preclinical mouse models to determine if UCART therapy can be improved using cytokines (IL-7 and IL-15), dual phosphoinositide 3-kinase delta/gamma inhibitors (duvelisib) and/or dual-targeted UCART.